Evidence-based Treatment for PTSD and Cardiovascular Disease Risk

Project Summary
Posttraumatic stress disorder (PTSD) is an often chronic and disabling mental disorder that can have adverse
consequences for health. Indeed, PTSD has been linked to heightened incidence of cardiovascular disease
(CVD) and mortality. Fortunately, there are highly effective treatments for PTSD, including evidence-based
psychotherapies (EBPs) and evidence-based antidepressants (EBAs). However, it is not yet known if these
evidence-based treatments for PTSD can reduce incidence of CVD or mortality, likely due to limitations of
existing epidemiologic datasets and the infeasibility of answering these questions in a randomized controlled
trial framework. The proposed project is distinctively poised to address these questions by harnessing a unique
data resource: the world’s most comprehensive PTSD treatment database, with up to 20 years of data on over
2 million veterans with PTSD receiving care in the United States Department of Veterans Affairs healthcare
system. Not only does this data resource have electronic health record (EHR) documentation of
pharmacotherapy for identifying EBA receipt, but we trained Natural Language Processing algorithms to
identify EBPs for PTSD, as well as changes in PTSD symptoms on a validated self-report measure. By
analyzing these comprehensive EHR data, including treatment receipt, PTSD symptom severity, CVD
diagnoses, and mortality, in a large, diverse sample of veterans, the proposed project is thus uniquely
positioned to address the impact of evidence-based treatment for PTSD on CVD outcomes. In Aim 1, we will
examine whether incidence of CVD and mortality (cardiovascular and all-cause) vary by evidence-based PTSD
treatment received (EBP, EBA, both EBP/EBA, no evidence-based treatment). We hypothesize that receipt of
evidence-based PTSD treatment will be associated with reduced incidence of CVD (e.g., myocardial infarction,
stroke, as documented with diagnostic codes in the EHR) and mortality, with variability by treatment type (e.g.,
EBPs may have more CVD benefit than EBAs given some findings of heightened CVD incidence with EBAs).
In Aim 2, we will investigate whether clinically significant improvement in PTSD symptoms, as well as
symptomatic remission, are associated with reduced CVD incidence and mortality, within type of treatment
received. Although treatment receipt alone may have implications for cardiovascular health, we predict that
treatment accompanied by clinically significant PTSD symptom improvement or symptomatic remission will be
more strongly associated with reduced CVD incidence and mortality. In Exploratory Aims, we will examine
these associations in models stratified by relevant patient characteristics, namely sex, race, and ethnicity. This
project brings together an interdisciplinary team of experts, a cost-effective use of an existing data resource,
and innovative questions to identify potential interventions for a leading cause of death and disability. Findings
have the potential to guide treatment decisions for patients with PTSD to best promote cardiovascular health
and inform new approaches to prevent and treat CVD in broader patient samples.

Public health relevance
Project Narrative Posttraumatic stress disorder (PTSD) is an often disabling, yet treatable, mental disorder that increases risk of cardiovascular disease (CVD), but it is unclear whether PTSD treatment can reduce incidence of CVD. By analyzing 20 years of comprehensive electronic health record data on evidence-based treatment, PTSD symptoms, and CVD outcomes in a large, diverse sample of veterans, the proposed project is uniquely positioned to address the impact of evidence-based treatment for PTSD on CVD risk. Findings have the potential to guide treatment decisions for patients with PTSD to best promote cardiovascular health and inform new approaches to prevent and treat CVD outcomes in broader patient samples.